2024 Cyclic Nucleotide Phosphodiesterases Gordon Research Conference and Gordon Research Seminar

Project Summary/Abstract
The 2024 Gordon Research Conference on Cyclic Nucleotide Phosphodiesterases (PDEs) will explore
bleeding-edge research driving the field to reconceptualize the fundamental biology and therapeutic potential
of targets within the cAMP/cGMP cyclic nucleotide signaling cascades. These pathways, which are regulated
by PDEs, modulate a number of critical physiological processes across the lifespan. As such, targets within
these signaling cascades have long been of high interest to drug discovery efforts, particularly in the context of
aging-related diseases. Indeed, we are seeing the fruits of our labor with many PDE inhibitors in the clinic
today and many more in active clinical trials. The program will include state-of-the-art approaches that shed
new light on the physiology of these cascades and reveal sophisticated mechanisms by which targets may be
manipulated for therapeutic gain. A fresh systems-level approach will be taken, with a given session focusing
on the same target in the context of different organs/diseases. By bringing together academic and industrial
scientists at all career stages from the fields of aging, cancer, cardiology, immunology & inflammation,
neuroscience/psychiatry, pulmonology, etc., the conference hopes to advance drug discovery efforts by
stimulating deep discussion of the potential for efficacy versus side effects. The GRC will include 62 speakers
(54 invited and 8 chosen from abstracts) and 2 interactive poster sessions. We invited such a high proportion
of our speakers to dramatically increase the diversity of our speaker pool (51.6% female, 14.5%
underrepresented minority by NIH and/or GRC definitions, 21% trainees). The pre-meeting seminar (GRS) will
have further talk and poster opportunities for undergraduate and graduate students, post-bacs, and post-docs,
as well as a career/mentoring panel. A ‘Power Hour’ in the main meeting will focus on addressing ways we all
can improve diversity and inclusion in science. We aim to foster an interactive, friendly environment in which
ideas can be freely exchanged independently of background or seniority. The GRC program will be organized
into nine morning and evening sessions entitled: (1) What we thought we knew and what (we think) we know
now, (2) Shining a light on cyclic nucleotide signaling pathways: advancements in biosensors and structure, (3)
The 'ins' and 'outs' of cyclic nucleotide signaling: intracellular cyclases and extracellular cyclic nucleotide
signaling, (4) Do unto those downstream as you would have those upstream do unto you: cyclic nucleotide
effectors, (5) Buggin' out with cyclic nucleotide signaling: non-mammalian PDEs, (6) 1 is not the loneliest
number: PDE1, PDE10, and PDE11, (7) Why are we so scared? Because PDE7, 8, 9, (8) The most explored:
PDE4, and (9) To cross or not to cross the streams, that is the question: PDE2 and PDE3 crosstalk. With
afternoons dedicated to social activities that facilitate networking and idea exchange, this GRC/GRS is sure to
advance the science of this exciting field, create cross-disciplinary collaborations, and inspire the next
generation of scientists.

Public health relevance
Project Narrative The 3’,5’-cyclic adenosine monophosphate (cAMP) and 3’,5’-cyclic guanosine monophosphate (cGMP) pathways, which are regulated by cyclic nucleotide phosphodiesterases (PDEs), modulate a number of critical physiological processes. As such, targets within these signaling cascades have long been of high interest to drug discovery efforts. This meeting will bring together scientists from a wide range of disciplines to discuss cyclic nucleotide signaling across numerous organs to promote cross-field fertilization of ideas, collaboration and the identification of novel mechanisms by which these signaling cascades can be harnessed for therapeutic gain.